Core 1: Resource for AcademIc SuccEss (RAISE)

The Resource for AcademIc SuccEss (RAISE) Core is a Shared Resource, available to support all Partnership participants. The RAISE Core will have two areas of emphasis: individualized career support for Early Stage and New Investigators (ESIs/NIs) and serving as the Ombudsperson for all participants.

The Core will act as a foundation that supports the individuals that make up the Partnership. The RAISE Core Leads have an extensive and complementary experience that allows them to act as coaches and advisors and identify appropriate resources to support Partnership faculty and staff. By providing individualized support for ESIs/NIs, the Core will directly address needs and knowledge gaps to enable faculty to increase their cancer research capability, become more effective collaborators and enhance their research on cancer health disparities. Regular individual meetings with ESIs/NIs will allow RAISE to provide advice, information, and access to professional development activities in a safe setting and timely manner. At any time, ESIs/NIs may request resources and/or activities for career growth. Such resources may include course release time for manuscript or proposal preparation, registration and travel for a focused professional development workshop and faculty coaching.

The heart of the Partnership is training and research collaborations between New Mexico State University and Fred Hutchinson Cancer Center. The Ombuds can serve to strengthen and improve collaborations and mentee-mentor relationships by facilitating communication to reveal differing expectations and work toward agreement of shared expectations. This increases cancer research capability because time in conflict is minimized and time and focus on research and education is maximized. This in conjunction with individualized faculty mentoring creates an environment that encourages the professional development of faculty and supports their engagement with the Partnership’s Guiding Principles (see Overall).

Public health relevance
Individualized support of ESIs/NIs in their professional career growth and the availability of Ombuds services will provide critical support to the entire Partnership, thereby facilitating the Guiding Principles of restructuring scientific environments, processes and engagement.